FATTY ACIDS AS BIOMARKERS OF DIETARY FAT INTAKE

There are, currently, no accepted sensitive and specific biological markers of total dietary fat intake for use in epidemiologic studies. Self-report measures of dietary fat may be seriously biased. By examining a combination of fatty acids, found in low concentrations, reflecting various components of a low-fat diet, it may be possible to develop a biomarker of fat intake. This hypothesis was tested in a controlled, dietary intervention in 66 post-menopausal women, who were randomized to consume either 17% or 34% of calories (kcal) from fat for 7 weeks. All food was provided and blood/tissue samples were taken twice at baseline and end of study. There were highly significant (P is less than 0.001) increases in relative proportions of many erythrocyte (RBC) and/or plasma phospholipid (PL) fatty acids with the low-fat diet. A linear combination of RBC C18:1(n-7) and C18:2(n-6), for example, differentiated the two groups very well at end of study (q=0.92), correlated strongly with change in fat intake (r=O.83) and moderately with baseline fat intake(r=0.51). These findings are highly promising but before these markers become widely applicable in epidemiologic settings, there are a number of issues that need to resolved. They are addressed as specific aims in this proposal, namely: (l) To test if the changes in PL and RBC fatty acids seen with the adoption of a low-fat, high carbohydrate diet are affected by weight loss: (2) To determine the time period of dietary intake reflected in PL and RBC fatty acid concentrations; (3) To ascertain if the changes in fatty acid concentrations found with post- menopausal women are generalizable to premenopausal women and men; and (4) To investigate the cross-sectional associations between adipose tissue fatty acid concentrations, RBC and PL fatty acids, and self-report measures of dietary fat intake. These aims will be addressed in a controlled, randomized dietary intervention, where 50 men (ages 21-79) and 50 women (ages 21-44) will be randomized to consume one of three possible diets for six weeks - (i) 34% of Kcalories (kcal) from fat, isocaloric; (ii) 17% kcal from fat, isocaloric; or (iii) 17%, with 33% calorie deficit, i.e. hypocaloric. Blood samples will be taken at baseline. and weeks 2, 4, and 6 after commencement of diet. Adipose tissue aspirates will be collected at baseline. Body composition will be measured at baseline and end-of-study.